Extended Stability Program Testing of Two Adenoviral HIV Vaccine Candidates

The purpose of this contract is to extend the Stability programs of two adenoviral-vectored HIV vaccine candidates currently being tested in clinical trials. The required services include performing defined, established assays for testing of the product stability as negotiated with the FDA. The contract will support the stability of these two HIV vaccine candidates using pre-approved stability protocols and tests per ICH guidance and pre-approved protocols.

Public health relevance
The contract will support the stability of two HIV vaccine candidates currently being tested in clinical trials.